Promoting Training in Clinical Pain Research as an Initiative of the Internet-delivered Management of Pain Among Cancer Survivors (IMPACTS) Trial

Abstract In recognition of the critical need for additional researchers devoted to and specializing in the area of clinical pain and pain management, the NIH has announced it is making training/career development funds available as a supplement to extant clinical trials funded under its HEAL Initiative. The investigative team and PI of one such HEAL Initiative parent grant (Internet-delivered Management of Pain Among Cancer Treatment Survivors— IMPACTS; supported by 3UG1CA189824-06S1) have identified an individual they believe is an exceptional candidate for the career development opportunities that would be afforded by this supplemental funding (Dr. Megan Bennett Irby) and are strongly endorsing her candidacy. Dr. Irby is an ideal candidate for this funding in that she already is a highly accomplished, early career researcher (particularly with respect to health disparities and community health issues) who is seeking additional career development opportunities that will enhance her capabilities and prospects for success as an independent, funded pain researcher. This application presents a thorough and thoughtfully crafted research training plan that would be undertaken by Dr. Irby in collaboration with members of the IMPACTS investigative team and other pain experts during the two years of the award. The training activities articulated in this application are complimentary to (and completely separate from) the key effort Dr. Irby already is contributing and will continue to devote as co-investigator for the IMPACTS grant. Our team is unanimous in the belief that, If allocated, unquestionably would serve to consolidate the focus of Dr. Irby’s research career upon the study of pain and pain management.

Public health relevance
PROJECT NARRATIVE This is a training application in response to the NIH HEAL Initiative’s call to support the career development of early career scientists seeking to establish themselves as pain researchers. The investigative team and PI of one such HEAL Initiative parent grant (Internet-delivered Management of Pain Among Cancer Treatment Survivors—IMPACTS; supported by 3UG1CA189824-06S1) have identified an individual they believe is an exceptional candidate for the career development opportunities that would be afforded by this supplemental funding (Dr. Megan Bennett Irby) and are strongly endorsing her candidacy. This application presents a thorough and thoughtfully crafted research training plan that would be undertaken by Dr. Irby in collaboration with members of the IMPACTS investigative team and other pain experts during the two years of the award.